ROLE OF PULMONARY MACROPHAGE IN ACUTE RESPIRATORY FAILURE

This protocol will determine whether pulmonary macrophage activation is increased in pediatric patients with ARF and ARDS compared to patients with ARF but not ARDS and control patients; whether pulmonary macrophage activation is correlated with airway neutrophil count and markers of neutrophil activation as well as IL-8 protein levels; whether pulmonary macrophage activation changes with time in Pediatric ARDS.